OSPEEC BPA TASK AREA 1 ORDER TITLED "STRATEGIC COMMUNICATIONS AND MEDIA RELATIONS" - SUPPLEMENT TO ADD DIR FUNDS FOR ORLOFF VIDEOS

The objective of this procurement is to provide expertise to the NHLBI in strategic communications planning and development of state-of-the-art media approaches and products on a range of heart, lung, blood, and sleep-related topics, including but not limited to: health disparities, cardiovascular disease, heart attack, high blood pressure, high blood cholesterol, obesity, physical activity, sleep and sleep disorders, asthma, chronic obstructive pulmonary disease (COPD), and sickle cell disease. Efforts will support the dissemination of new research findings, as well as new products for the public, patients, and health professionals, and could include, through the work with partners, new clinical practice guidelines. New social media vehicles, as well as traditional media, should be used to communicate with key stakeholders, including patients and caregivers, grantees, professional societies, policymakers, health professionals, and the National Institutes of Health (NIH) and U.S. Department of Health and Human Services (HHS) leadership.